OPT-FRESH: Optimizing Online Purchasing of Fruits, Vegetables, and Legumes for Low-Income Families

PROJECT SUMMARY
Food insecurity, that is, the lack of consistent access to nutritious and affordable food, is associated with poor
diet, increased cardiovascular disease (CVD) risk, and has a negative long-term impact on the economy
through increased health care costs. CVDs and food insecurity disproportionately affect Black and Hispanic
families, and most of these racial health disparities can be attributed to social determinants of health, including
poor access to healthy foods. A recent policy in the U.S. authorized the Supplemental Nutrition Assistance
Program (SNAP) benefits to be used online to increase grocery access and promote healthy eating. Although
online grocery shopping has been growing among populations of low-income, the selection of fruits, vegetables,
and legumes (FVL), which are protective against CVD, is lower than in-store. Distrust of online hired shoppers'
choices, fear of losing money on unsatisfactory purchases, and impulse of unhealthy food purchases have been
the major barriers to online healthy food selection. Thus, there is a need for intervention packages that are
effective, economical, and easily scalable into policies that address CVD-related outcomes and improve health
equity. The proposed work will use a highly efficient methodological approach, the Multiphase Optimization
Strategy (MOST), to test three experimental components aimed at barriers to online healthy food selection,
called OPT-FRESH. This approach addresses weaknesses in prior studies, which cannot determine which
elements of multicomponent interventions meaningfully improve outcomes. 360 families with children living
in low-income urban communities of NYC will be randomized to receive some combination of the three
experimental components for 12 weeks: 1) weekly text messages to improve the trust in online grocery services
(off/on); 2) weekly match-up to $10 as a financial incentive for purchasing FVL online targeting loss aversion
(off/on); 3) weekly instant shoppable grocery lists of culturally tailored meal suggestions using SNAP recipes
targeted at impulse purchases (off/on). Delivery fee waiver and a tutorial video addressing digital literacy will
be constant components to promote equity in participant enrollment. Aim 1 will determine the combination(s)
of the three experimental components that improve overall household FVL purchase and food insecurity
(primary outcomes) and FVL intake of children (secondary outcome). Aim 2 will identify the optimized
intervention that balances component(s) that are affordable and scalable (high adoption, implementation,
maintenance) that still produce meaningful effects on the outcomes, using decision analysis for intervention
value efficiency. Aim 3 will determine the mechanistic effects of the three intervention components on the
outcomes using factorial mediation analysis. Working with community-based organizations and nutrition and
hunger relief programs in NYC, a grocery delivery service, and a team with unparalleled expertise in
experimental trials, policy, and MOST, we will implement optimized, affordable, and scalable intervention
strategies to improve neighborhood food access and ultimately CVD outcomes in socially vulnerable families.

Public health relevance
PROJECT NARRATIVE Cardiovascular diseases (CVDs) disproportionately affect Black and Hispanic families, with most of these racial health disparities attributed to social determinants of health, including poor access to healthy foods and food insecurity. Online grocery services offer a promising solution to enhance access to nutritious and affordable foods, particularly in communities with low availability of brick-and-mortar grocery stores. Our study examines optimized, scalable, and affordable intervention strategies implemented in both private (online grocery services) and public sectors (Supplemental Nutrition Assistance Program) to improve CVD-related outcomes in socially vulnerable families.